Novel Hybrid Computational Models to Disentangle Complex Immune Responses

Most quantitative models in biomedical research have been formulated by ordinary differential equations
(ODEs). Despite the great contributions ODEs have made to biology and beyond, the high-dimensional,
time-dependent factors of the immune system still pose a significant challenge to the predictive value of
ODEs as it would require several hundred equations and thousands of parameters to be estimated. The
recent rise of machine learning as a powerful computational tool to integrate large datasets presents a
special opportunity to deal with the inherent complexity of biological systems. However, machine learning
approaches do not consider the mechanistic knowledge of the underlying interactions. Preliminary studies
that combine ODEs and machine learning highlight that these computational algorithms could be on the
cusp of a major revolution. Remarkably enough, however, no parameter estimation theory exists to
integrate simultaneously both approaches. We propose to create new hybrid models and test their
predictions in a mouse viral coinfection system to address a central vexation for infection biology which is
how and when to modulate immune responses to mitigate mortality during lethal respiratory viral infection.
At the interface between mathematical and life sciences, we will develop and analyze a novel suite of
computational models that will integrate the underlying biological mechanisms to manage ill-posed
problems and explore massive design spaces, allowing for robust predictions from complex biological
systems. To validate and test our novel and foundational mathematical approaches, we will generate the
biological data from a mouse infection system with a mild viral pathogen (rhinovirus) two days before
infection with a lethal viral pathogen (influenza) that results in reduced disease compared to single infection
alone. We hypothesize that this system can train our mathematical models in a natural way how the innate
immune system can be manipulated to reduce mortality to lethal infections and beyond. Key model
predictions will be tested by targeted immune system manipulation during lethal infection, paving the way to
understanding the role of complex immune interactions in respiratory viral disease pathology.

Public health relevance
Innate immune manipulation holds enormous promise for reducing the severity of infections and other human diseases. A new family of computational tools will be developed for predicting the multidimensional time events of the innate immune that prevent mortality during lethal respiratory viral infections. Without such a mathematical framework in place, the design of immunotherapies will be slowed, or worse, dangerous, and faulty.